Cancer Genomics Shared Resource

CANCER GENOMICS SHARED RESOURCE Project Summary Next-generation sequencing (NGS) and microarray technologies are essential resources for investigating the genomic and molecular underpinnings of cancer formation, progression, and clinical outcomes. The primary objective of the Cancer Genomics Shared Resource (CGSR) is to maximize the scientific and clinical impact of research by Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) members. This is accomplished by providing rapid and cost-effective access to state-of-the-art genomic technologies, while creating a unifying environment that cultivates scientific awareness, education, and collaboration. The CGSR supports the WFBCCC's mission by providing cancer-prioritized access to comprehensive microarray and NGS technologies and offers seamless data flow through to the Biostatistics and Bioinformatics Shared Resource - for bioinformatics support. In October 2014, at the instigation of Director Pasche, the former Microarray Core Laboratory (2002-2014; which received a score of “excellent” in the prior critique) was renamed the Cancer Genomics Shared Resource to reflect the integration of the WFBCCC's microarray core competencies with the NGS expertise of the Center for Genomics and Personalized Medicine Research. This new joint-Center partnership reflects the strategic plans of the WFBCCC and the Wake Forest School of Medicine (WFSOM), as well as supporting priority recommendations of the WFSOM Centers and Cores Advisory Committee. The CGSR provides cutting-edge genomic services, prioritizes cancer-specific research, creates an optimal environment for the Institution's rapidly developing precision medicine initiative, and seamlessly integrates with other key Shared Resources within the WFBCCC to promote integrated, high-quality workflows for cancer genomics research. The CGSR is led by Co-Directors Lance Miller, Ph.D., and Greg Hawkins, Ph.D., who have established records in cancer genomics research, and is operated by four experienced technicians (two at 100% effort, one at 50% effort and one at 5% effort). A bioinformatician devotes 30% of effort to CGSR daily operations. In the most recent grant year (11/01/14-10/31/15), the CGSR operated at 80-90% FTE utilization to provide 1,144 services to 20 investigators, 75% of which were WFBCCC investigators. Compared to previous years, the CGSR doubled its service output and increased its cancer-specific service output by approximately 50%. The CGSR directly contributes to the scientific achievements of WFBCCC investigators by generating high-quality and cost-effective data that will translate into new discoveries, publications, grant awards, and grant applications. Further development of CGSR's role in supporting the development and productivity of WFBCCC Disease-Oriented Teams and the continued development of seamless workflows across Shared Resources are expected to enhance translational genomics initiatives at the WFBCCC.